Enhancing Cardiovascular Risk Prediction and Treatment Response in Sleep Apnea Patients Using Advanced AI-based Transformer Models in Multi-Modal Sleep Data

PROJECT SUMMARY
Obstructive sleep apnea (OSA) affects arounds 24 million Americans and increases cardiovascular (CV)
morbidity and mortality. The primary treatment for OSA is continuous positive airway pressure (CPAP) therapy,
but CPAP usage has not been shown to reduce CV events in clinical trials. One major limitation to our
understanding of the OSA-CV disease link is the current diagnostic and prognostic marker of OSA: the apnea-
hypopnea index (AHI). AHI does not well predict individual CV disease risk, and reducing AHI to normal levels
does not improve CV disease outcomes. Thus, better CV risk prediction tools are needed for OSA patients.
Further, being at high risk does not always translate to significant benefits from treatment. However, there is
currently no way of forecasting which OSA patients will receive the most benefit, or harm, from CPAP therapy.
Patients with suspected OSA undergo a comprehensive sleep study, known as a polysomnogram, either at home
or in a lab. Polysomnograms collect up to 20 channels of data, including heart rate, muscle movements, and
brain activity; but nearly none of this data is used in clinical practice and what data is used is often compressed
into summary statistics (e.g., average heart rate over 8 hours). The goal of this proposal is to use a novel artificial
intelligence technique known as transformer-based neural networks, or transformers, to analyze the multimodal,
longitudinal data available from a polysomnogram in order to better predict CV risk and treatment response in
OSA patients. To accomplish this, we will leverage data from existing diverse epidemiological datasets (Aim 1)
and randomized clinical trials testing CPAP versus usual care on CV disease outcomes (Aim 2) to fine-tune our
pre-trained sleep specific transformer model. We will compare our risk prediction (Aim 1) and treatment response
(Aim 2) tools to clinical metrics such as the AHI to demonstrate their improved predictive utility. Our approach is
innovative in its use of cutting-edge artificial intelligence and estimation of treatment heterogeneity techniques.
Transformers have become a foundational and transformative technology in artificial intelligence due to their
exceptional ability to handle sequential data and capture complex patterns. Their influence on the artificial
intelligence landscape is profound, and they continue to drive innovations and improvements in artificial
intelligence research and technology. Further, our proposal has high significance given the prevalence of OSA,
and the lack of available tools to predict CV risk and CPAP treatment response specifically in OSA patients. In
particular, a tool that could predict whether an OSA patient will actually receive benefit from CPAP would
revolutionize the field. Our approach will improve clinical risk prediction, treatment guidelines, and patient
outcomes, as well as possibly extract novel health-relevant features of sleep for future clinical applications and
mechanistic insight into OSA, CV disease, and the link between the two, significantly impacting the field of sleep
medicine.

Public health relevance
PROJECT NARRATIVE There is currently no way for physicians to predict which obstructive sleep apnea (OSA) patients are at highest risk for cardiovascular events, or which patients are likely to respond to continuous positive airway pressure therapy, the primary treatment for sleep apnea. The goal of this proposal is to use a novel artificial intelligence technique, known as transformer-based neural networks, to analyze complex sleep study data in order to predict cardiovascular risk and treatment response in OSA patients. Our approach holds the potential to transform cardiovascular risk prediction and outcomes in sleep medicine, and may uncover new health-relevant sleep features for clinical applications and to provide deeper understanding of the connections between OSA and cardiovascular disease.